Novel Wiring Catheter for Crossing Complex Chronic Total Occlusions

Project Summary/Abstract
We propose to develop an innovative wiring catheter system to reliably direct subintimal crossing and re-entry
into the artery true lumen during treatment of complex arterial chronic total occlusions (CTO). The proposed
system will improve techniques for treating complex CTOs during percutaneous coronary and peripheral artery
interventions (PCI). Atherosclerosis drives development of coronary artery, cerebrovascular, and peripheral
arterial disease. Improved CTO crossing devices and techniques will allow more operators to perform these
procedures and improve patient care. The proposed project investigates key elements of a novel guided re-entry
catheter system to be used in a rendezvous maneuver to increase the precision, speed, reliability, and safety of
retrograde CTO PCI crossing. A prototype device will be developed and evaluated.

Public health relevance
Project Narrative Atherosclerosis is the leading cause of vascular disease, which accounts for 38% of all deaths in North America. Coronary artery disease is the leading cause of death from atherosclerosis, with over 500,000 deaths per year in the US alone. Peripheral artery disease affects more than 200 million persons worldwide, including at least 8.5 million persons in the United States, and is associated with high rates of cardiovascular events and death as well. Chronic total occlusions (CTO) are a major challenge in coronary and peripheral artery treatment. We propose a novel CTO crossing approach to ensure expedient and precise re-entry from the subintimal tissue space into the true lumen to enable angioplasty and stenting of the CTO stenosis.